NCANDA: Data Analysis Resource - Uploading Legacy Data to NDA

PROJECT SUMMARY
This supplement requests funds to make the longitudinal data acquired in the first eight years by the National
Consortium on Alcohol and Neurodevelopment in Adolescence (NCANDA) study publicly available via the
National Institute of Mental Health Data Archive Repository (NDA). From 2013 to 2015, the 5 sites of NCANDA
recruited a diverse community sample of mostly no-to-low drinkers (12 to 21 years old, N=831) and tracked
them since then (93% retention rate). Monitoring has involved annually acquired multimodal neuroimaging
(MRI, DTI, resting state fMRI) and cognitive, clinical, and behavioral data. While data acquired by the current
funding cycle (a.k.a. NCANDA-A), i.e., from 9 years onwards, are uploaded to NDA, no funds are budgeted for
archiving the longitudinal data of the first 8 years to NDA. The supplement would provide those funds and thus
give complete public access to this unique and valuable longitudinal data set using a single data structure, a
critical step in easing analysis of the impact of heavy alcohol drinking on the NCANDA cohort.
NCANDA-A has 4 main aims. With respect to Aim 1, the consortium has been investigating the impact of
excessive alcohol drinking during adolescence and emerging adulthood on subsequent developmental
trajectories of cognitive performance, brain structure and function, and psychopathology. For Aim 2, NCANDA
has been identifying neurodevelopment patterns describing the extent to which alcohol's effects on brain
structure and function resolve or persist during desistance after binge drinking. Aim 3 focuses on data-driven
analysis to identify adolescent biological, environmental, and behavioral factors (e.g., age of drinking onset)
that forecast excessive drinking during early adulthood. Regarding Aim 4, NCANDA-A has been quantifying
the impact of the COVID pandemic on life stress and social, emotional, and economic wellbeing and their
relations with alcohol use patterns. For each aim, sex differences in development, alcohol use patterns and
history, impact of alcohol use on the brain, and sex-differentiating psychosocial factors are tested.
Since the initiation of the study, the NCANDA sites have been uploading their data onto servers of the
NCANDA Data Analysis Resource (DAR), whose administrative PI is Dr. Pohl. With respect to NCANDA-A, the
DAR manages the data in line with five aims. Aim D1 ensures that procedures for collection and quality control
of neuroimaging, neuropsychological, and clinical assessment data are standardized. For Aim D2, the DAR
has been advancing the existing informatics infrastructure for integrating data collected across all sites. With
respect to Aim D3, they are enhancing macrostructural, microstructural, and functional neuroimage processing
and analysis. Regarding Aim D4, the DAR creates machine (deep) learning frameworks identifying predictive
markers of early adulthood drinking. Finally, for Aim D5, they maintain data sharing and distribution systems
for consortium PIs and the scientific public at large. Starting with NCANDA-A, data from nine years onwards
will be shared on NDA. To make the first 8 years of data accessible also via NDA is the aim of this supplement.

Public health relevance
PROJECT NARRATIVE Heavy alcohol drinking during adolescence is known to disturb brain development and functioning and increase risk of drinking problems in adulthood, but the extent of the lingering effects of youthful drinking on adult functioning remains unclear. The goal of NCANDA is to follow youth who have and have not engaged in hazardous drinking to determine alcohol's influence on the brain, cognition, emotion, and life activities in emerging adulthood when young men and women are establishing themselves in careers, relationships, and independent living. In this supplement, we will make data acquired by NCANDA in the first eight years public available via the NDA server, which will ease access of this valuable data set for scientific public at large.